Evaluating CT/Xray imaging-correlated impedance-based metrics for predictive surgical osseointegration and injury prevention

PROJECT SUMMARY/ABSTRACT
Clinical Importance: Almost 15 million dental implants were placed worldwide in 2021, with 3 million of these
procedures taking place in the United States. Implants have been linked to maintaining proper nutrition intake,
chewing ability, and quality of life, particularly essential for a rapidly aging population. The demand for implants
is projected to increase up to 23% by 2026, with the largest rise expected among those aged 65-74 years –
patients with the highest bone quality variability. The procedure itself requires an osteotomy be drilled into the
mandible or maxilla (depending on site of implant) so that the implant can be seated within the boney structures of
the jaw. A significant challenge to creating the initial osteotomy is ensuring that no critical structures (i.e., nerve or
sinus) near to the bone are breached leading to severe post-procedure morbidities. Further, understanding patient-
specific bone integrity at the implant site is critical for proper implant selection and use of adjunctive procedures such
as bone densification to ensure successful osseointegration and long-term stability. Clinical Limitations: Despite
the widespread use of cone beam CT (CBCT) for preoperative anatomic assessment, significant challenges
remain in accurately placing the implant and quantifying bone quality from Hounsfield (HU) measurements.
Specifically, CBCT struggles to visualize boney microstrucutres, particularly in trabecular cancellous bone which
has increasingly been recognized as critical for implant loading, stability and overall osseointegration. Further,
while pre-operative imaging and use of guidance has helped significantly improve surgical outcomes, iatrogenic
injury to high-risk structures still occurs in ~10-20% of the cases, resulting in significant short- and long-term
morbidity. Specific Objectives: This proposal aims to leverage a novel multimodal dataset uniquely integrating
radiomics, "impediomics" and intraoperative surgical tracking data. Features from more 600 unique drill depths
within 105 osteotomies from an in vivo large animal model yielded a >20k impedance feature dataset with novel
insights including ultra-high resolution micro-CT scans of cortical and trabecular bone microarchitecture,
impedance-based electrical property features collected in real-time while drilling, and intentional breaches of
high-risk nerve and sinus structures. This dataset presents a unique opportunity to evaluate novel potential
imaging-correlated impedance-based metrics for predictive surgical osseointegration and injury prevention. We
aim to 1) expand this dataset through additional advanced processing and feature extraction to derive
impedance-based "impediomics” and radiomics features (Aim 1), 2) explore machine learning models, including
multi-feature approaches to detect high-risk anatomic interfaces that could provide real-time feedback during
osteotomy to mitigate iatrogenic injury risk (Aim 2), and 3) leverage our novel impedance features and unique
ultrahigh-resolution micro-CT images to develop potential metrics for precise site-specific bone quality
characterization at prospective implant sites. Such a capability could be transformative for delivering
personalized treatment plans that maximize outcomes while mitigating complications for dental implant patients.

Public health relevance
PROJECT NARRATIVE Comprehensive assessment of patient-specific bone quality and identification of high-risk anatomic interfaces are critically needed to improve dental implant treatment planning, mitigate iatrogenic injury risks during implant delivery, and ensure predictable osseointegration for long-term success in a rapidly aging population. We propose to leverage a unique pre-existing multimodal dataset including radiomics of bone microarchitecture, “impediomics” sensitive to multiscale bone properties including nearby high-risk anatomy, and intraoperative surgical tracking to develop novel quantitative ‘biomarkers’ in order to improve acute and long-term implant treatment success. An objective metric able to interrogate the mechanical properties and avoid acute injury at the osteotomy site could be transformative for delivering patient-specific treatment plans that maximize outcomes while mitigating complications.